Piloting a culturally adapted multilevel suicide prevention intervention in schools for Black youth and their families

Project Summary/Abstract
The goal of this proposed study is to pilot test and evaluate the preliminary effectiveness of a school-based
suicide prevention intervention tailored specifically for Black youth and those connected to Black youth (e.g.,
families and school personnel). Suicide was recognized in 2018 as the 2nd leading cause of death for 10 to 14-
year-old Black adolescents in the U.S., yet there are few evidence-based suicide prevention interventions
designed to account for the cultural factors that influence Black youth's risks for suicidality. Further – although
universal school-based suicide prevention programs have great potential to alleviate disparities in access to
mental health resources – most school-based suicide prevention interventions are administered to high school
students. Some researchers have begun to implement prevention interventions among middle school-aged
youth, but we know little about the effect universal school-based suicide prevention interventions could have
for Black students residing in underserved communities. To redress this gap, we propose modifying an existing
intervention with culturally adapted content by conducting a pilot RCT to assess preliminary effectiveness,
tolerability, and feasibility. The Signs of Suicide (SOS) program is a school-based intervention that has
demonstrated reductions in suicide attempts among middle and high school students by identifying knowledge
and attitudes towards depression and suicide as key mechanisms that mediate the relation between
intervention participation and a significant reduction in suicide attempts. Thus, it is important to consider how
prioritizing these two mechanisms – knowledge and attitudes towards depression and suicide – may differ for
Black youth whose perceptions of knowledge and attitudes of suicide may be culturally bound and influenced
by stigmatized beliefs regarding help-seeing for mental health concerns. Parents views about stigma and
school personnel's familiarity with suicide prevention resources may also influence Black youth's knowledge
and attitudes, thus affirming the necessity of a multilevel suicide prevention intervention. We therefore propose
a cultural adaptation of the SOS program that aims to: 1) Tailor the SOS intervention videos to include
culturally adapted strategies for navigating stigma of receiving mental health treatment; (2) Develop culturally
adapted curricula that trains parents and school personnel to (a) recognize suicide risk factors for Black youth;
and (b) refer students to local mental health treatment services; and (3) Conduct a pilot randomized controlled
trial (n=300) to assess feasibility, tolerability, and acceptability of reducing suicidality among Black youth
across three intervention conditions (standard SOS condition; culturally adapted SOS condition; culturally
adapted SOS + parent and school personnel training condition). Pre-test scores will be compared at post-test,
3-month, and 1-year follow up. Results from this study will advance our understanding of factors that contribute
to and protect against suicidality in Black youth, while also providing a foundation to test and refine study
procedures to implement the intervention in a larger cohort of students.

Public health relevance
Project Narrative In 2018 suicide was reported as the 2nd leading cause of death among Black Americans ages 10-14-years-old; suicide prevention resources designed specifically for Black youth, however, remain scant. Where therefore propose the development of a multilevel cultural adaptation of the Signs of Suicide (SOS) prevention program and will conduct a pilot randomized controlled trial with students, parents, and school personnel in Chicago Public Schools to assess feasibility and examine underlying mechanisms that contribute to suicidality among Black youth. Findings derived from this project will contribute to public health priorities by offering unique insight into the factors that either prevent or promote suicide among Black youth and could be replicated in other schools serving Black students and their families across the nation.